Restoration of Postural Control After Spinal Cord Injury

Project Summary/Abstract
The inability to maintain upright body posture and balance is one of the major motor disorders following
spinal cord injury (SCI). In our previous, NIH-supported studies, specific distortions in operation of spinal
postural mechanisms (networks) underlying each of three main phenomena related to SCI – spinal shock, the
development of spasticity, and the recovery of postural functions have been demonstrated in an animal model
(rabbit). We also demonstrated a crucial role of supraspinal postural networks in control of posture. A general
goal of the present project is to explain effects of SCI on postural functions on the basis of SCI-caused
changes in the operation of the corresponding supraspinal neuronal postural networks. Clinical data suggest
that most SCIs are incomplete. Incomplete SCIs cause severe distortions in the interaction between the brain
and the spinal cord. This leads to a dramatic decrease or asymmetry of muscle tone and postural limb reflexes
resulting in the inability to stand and maintain balance. Our Aim 1 is to analyze the effects of incomplete SCIs
(lateral and dorsal hemisection, LHS and DHS) on the operation of supraspinal postural networks, and to
explain postural deficits by the changes in the activity of specific ascending and descending pathways. We
have developed a novel technique that allows to perform “reversible LHS or DHS” repeatedly many times. This
allows studying postural responses and the activity of individual neurons of the ascending and descending
pathways under two conditions: (i) when the brain is connected to the spinal cord and (ii) during LHS or DHS,
when the connection between the spinal cord and the brain through lateral or dorsal pathways, respectively, is
temporarily blocked. Previously we have shown that, after DHS and LHS, postural functions recover in a few
weeks. Our Aim 2 is to analyze the activity of supraspinal postural networks in recovered LHS- and DHS-
subjects, and to explain the recovery by changes in the activity of specific populations of ascending and
descending neurons. For this purpose, we will (i) record the activity of individual neurons of the supraspinal
postural networks during postural performance in recovered LHS- and DHS-subjects, and (ii) compare the
results with those obtained in intact subjects and in subjects after acute LHS and DHS. Our Aim 3 is to analyze
the role of different descending pathways in control of specific aspects of postural behavior in recovered LHS-
and DHS-subjects, and to explain the recovery by the changes in the functional role of particular pathways. For
this purpose, the effects of the chemogenetic activation/inactivation of different supraspinal pathways on the
performance of various postural tasks in intact and recovered LHS- and DHS-subjects will be compared.
This study will provide unique information about the SCI-caused changes in the activity of supraspinal
neuronal networks, which are responsible for the motor deficits, as well as about the changes underlying
functional recovery in subjects with incomplete SCI. This information is clinically relevant as a basis for
designing new rehabilitation strategies for recuperating postural functions in patients with postural deficits.

Public health relevance
Project Narrative Due to severe damage of the nervous control of posture and balance, spinal cord injured patients are bound to a wheelchair and their rehabilitation constitutes both clinical and social problems. The proposed project will provide unique information about changes in supraspinal postural networks underlying distortion and recovery of postural functions after incomplete spinal cord injuries (that are most common cases in spinal cord injured patients). The present project will contribute to development of rehabilitation strategies aimed at restoration/improvement of postural functions in spinal cord injured patients, as well as in patients with postural deficits of other etiology (e.g. caused by stroke, Parkinson’s disease, etc.).